Addressing Social Determinants of Health in Young Adults with Type 1 Diabetes Through Comprehensive Assessment, Responsiveness, and Engagement (T1CARE)

ABSTRACT
Adverse social determinants of health constitute major barriers to type 1 diabetes (T1D) management and
drive disparities in diabetes outcomes. Young adults with T1D tend to have the worst glycemic control levels of
all age groups, with Black and Hispanic young adults experiencing the highest complication rates and mortality.
While social risk factor screening-and-referral services could improve health outcomes, convincing data on
their effectiveness are largely lacking. Results from the Accountable Health Communities Model found this
intervention ineffective with respect to addressing social needs. As opposed to classifying people by social risk
factors and assisting them in accessing generic services, a personalized intervention, fully responsive to the
complex, problematic situation of each person may be required, especially to address the unique needs of
young patients with T1D. However, such an approach remains untested against care as usual. To fill this
knowledge and care gap, we propose a pilot randomized trial to test the feasibility and preliminary efficacy of
T1CARE: Comprehensive Assessment Responsiveness and Engagement. T1CARE includes in-depth
assessment of social and clinical needs and a hybrid community health worker-patient navigator approach to
address social and clinical needs of young patients with T1D. We have partnered with a community-based
organization (Project Access-New Haven), which has an established record of removing barriers to clinical
care and addressing social needs for underserved populations. Our specific aims are: Aim 1: Determine the
feasibility of implementing screening for adverse social determinants of health (SDOH) for young patients with
T1D and randomly linking patients who report ≥1 adverse SDOH to either T1CARE or usual care: (1.1):
Characterize what is the usual care these patients receive during the experimentation period to determine what
aspects of the intervention are present usually, including “dose” and intensity. (1.2): Evaluate the feasibility of
recruitment and retention of trial participants, rates of SDOH screening and identification of adverse SDOH,
acceptability of the intervention, completion of study procedures, and collection of clinical outcome data. (1.3):
Assess the extent to which screening for SDOH and T1CARE can be integrated into clinical practice routines
using Normalization Process Theory and its Toolkit. Aim 2: Estimate preliminary signals of the efficacy of
T1CARE vs. usual care for the following outcomes at 6 months post intervention: (2.1) resolution of adverse
SDOH; (2.2) patient-reported outcomes, including diabetes distress (measured using the Diabetes Distress
Scale), illness intrusiveness (Illness Intrusiveness Scale), and global quality of life (evaluated using a 1-item
analogue scale); and (2.3) clinical outcomes, specifically changes in HbA1c levels. This study will establish a
robust partnership model with Project Access-New Haven, and estimate feasibility, normalization, and efficacy
of an innovative approach, T1CARE, for testing in future larger hybrid effectiveness-implementation trials.

Public health relevance
PROJECT NARRATIVE Social risk factors, such as unstable housing or food insecurity, contribute to poor outcomes for individuals with type 1 diabetes. In partnership with Project Access-New Haven, a community-based organization, we propose to test an innovative approach, T1CARE (Comprehensive Assessment Responsiveness and Engagement), which links young patients with social risk factors with a Community Health Navigator who works with them to remove barriers to care and address social needs.